An Improved Robotic Electrophysiology Platform for Arrhythmia Ablation

Arrhythmias result from disorganized electrical signals within the heart leading to irregular contractions and are
a leading cause of death in the US. Ventricular tachycardia and fibrillation are the most serious arrhythmias
resulting in 300k annual US deaths, followed by 130k US deaths due to atrial fibrillation (AF). With a
prevalence of 6M in the US, AF is the most common arrhythmia, resulting in 750k annual US hospitalizations.
AF-associated medical costs will exceed $50B by 2035. AF therapies first rely on pharmaceuticals to prevent
blood clots and to restore rhythm. If these approaches fail, electrophysiology (EP) procedures are performed
which pass electrical currents (or coolants) through the catheter’s tip to destroy tissues disrupting proper
electrical signals. However, manual catheters rely on complex tension-wire designs operated from a meter
away which makes effective catheter control difficult, leading to injury and AF recurrence.
Robotic platforms have struggled to improve catheter control for decades. Most robotic systems manipulate
standard manual catheters; however, learning curves remain high and catheter tip control is unimproved.
Magnet-based systems that use magnetic catheters improve control; however, the systems are impractically
large, difficult to use, and require a custom angiography suite. Because all existing robotic solutions remain
prohibitively expensive, such systems are found only in a limited number of high-volume centers despite that
more than 80% of all hospitals providing ablation are lower-volume centers. What is needed is an affordable
and workflow-friendly robotic technology that improves catheter control and enables expertise within high-
volume EP centers to be remotely shared with lower-volume centers for training and procedural support.
UNandUP’s MAP-EP (Magnetic Assistive Platform for EP) system controls novel linkage-based magnetic
catheters using a magnet mass 50X smaller than previously possible. As a result, the MAP-EP system can be
installed into existing digital angiography suites without the need for a new c-arm or room construction.
Because energy is not expended fighting catheter restoring forces, low magnetic fields achieve stable,
accurate, and precise heart wall contact. The technology complements standard EP workflows, is affordable
for low-volume EP centers, and provides telerobotic access to expertise within high-volume centers.
In the Phase I effort, a prototype magnet workstation was constructed, novel magnetic materials were
developed to manufacture smaller and more complex magnets than previously possible, and prototype
catheters were successfully built and assessed using known heart phantoms. I-Corps and TABA participation
were completed, and FDA pre-submission meetings were held in support of mapping [510(k)], ablation (PMA),
and Early Feasibility Studies. For the proposed effort, UNandUP will develop preclinical versions of its system.
Efficacy studies will be completed using known beating heart phantoms. Biocompatibility testing and large-
animal safety and feasibility studies will be conducted following published methods.

Public health relevance
Arrhythmias are a major cause of US mortality with ventricular fibrillation, ventricular tachycardia, and atrial fibrillation resulting in 430,000 annual deaths. Although catheter ablation is a proven treatment option, as reinforced by the HRS/EHRA/ECAS/APHRS/SOLAECE Expert Consensus Statement, control of ablation catheters can be complex, resulting in imprecise and unreliable heart-wall contact leading to an increased likelihood of injury and arrhythmia recurrence. UNandUP (short for “Unmet Needs and Underserved Populations”) is developing an affordable angiosuite compatible platform which uses low magnetic fields to overcome prior limitations related to electrophysiology catheter navigational accuracy, stability, and applied forces.